Targeting the hepatic adropin signaling pathway in obesity

PROJECT SUMMARY/ABSTRACT
Obesity is the second leading cause of preventable death in the United States. Obesity is a complex nutritional
and genetic disorder that is driven by energy imbalances, and serves as a fundamental risk factor in various
pathologies including coronary artery disease, diabetes, non-alcoholic fatty liver disease, and atherosclerosis.
The cellular and molecular mechanisms that drive obesity-related disease in different tissues are not fully
elucidated, and this represents an impediment to the development of effective and efficient treatments. Adropin
is a recently characterized liver- and brain-derived peptide hormone that exerts powerful effects on fuel
substrate metabolism in peripheral tissues. Adropin levels are significantly reduced in obese and diabetic
human subjects, and this decrease is linked to increased adiposity and impaired glucose homeostasis.
Furthermore, adropin depletion has been linked with the development of liver-associated obesity diseases
such as NAFLD and NASH. In this fellowship application, we will determine the molecular signaling pathways
underlying adropin function in liver fuel metabolism, and investigate its protective effects against NAFLD and
NASH. In Aim 1, we will determine how adropin associates with the cell membrane receptor GPR19 to regulate
hepatocyte fuel metabolism. In Aim 2, we will determine if GPR19 is necessary for the protective effects of
adropin against hepatic injury. By combining cutting-edge metabolic techniques and a comprehensive training
plan, this fellowship will allow me to prepare for the next stage of my career in metabolic research and scientific
education.

Public health relevance
PROJECT NARRATIVE Obesity is the second leading cause of preventable death in the United States, and serves as a fundamental risk factor in various pathologies including coronary artery disease, diabetes, non-alcoholic fatty liver disease, and atherosclerosis. The cellular and molecular mechanisms that drive obesity-related disease in different tissues are not fully understood, and this represents an impediment to the development of effective and efficient treatments. In this project, we will examine whether a novel cellular receptor protein, GPR19, is involved in the protection from obesity-related liver disease.